Elucidating the Mechanisms of Microtubule Regulation at the Cellular Cortex

Project Summary: Microtubule (MT) dysfunction is linked to various developmental and neurological
disorders. While significant advances have been made in understanding MT dynamics in the cytoplasm, their
regulation at cellular membranes remains poorly understood. The primary objective of this proposal is to
investigate how MT dynamics is regulated at the interface of the plasma membrane and the cytoskeleton,
known as the cortex. My recent postdoctoral research suggests that phase separation-dependent
condensation, a process of protein de-mixing, may serve as a cellular mechanism to compartmentalize cortical
MT regulators, such as EFA-6, and modulate MT dynamics locally. The proposed study aims to uncover the
mechanisms governing EFA-6 phase separation at the cortex and its effect on EFA-6's MT regulatory
activity. This study will identify novel factors that regulate MT dynamics at the cortex, elucidate their
mechanisms of action, and characterize their roles in MT-membrane interactions dependent cellular
functions. Unraveling the MTs regulations at this interface will offer new insights into the fundamentals of MT
homeostasis and could inform the treatment of diseases associated with MT dysfunction, such as microcephaly,
amyotrophic lateral sclerosis, and Parkinson’s disease. C. elegans will be used as the model organism due to
its well-characterized MT dynamics, genetic tractability, and transparency for live-cell imaging. The project will
focus on two specific aims: 1) Investigating the mechanisms by which EFA-6 undergoes phase separation and
modulates MT dynamics, using proximity labeling, in vitro assays, and genetic analyses (K99 phase). 2)
Identifying and characterizing novel cortical MT regulators and investigating their roles in regulating membrane
functions through genetic, microscopic, and biochemical approaches (R00 phase). This proposal will deepen our
understanding of how cells regulate MT dynamics at the cortex to achieve specific membrane morphologies and
functions. Furthermore, this study will uncover novel regulators of MTs, shedding light on MT homeostasis under
both normal and stress conditions. Overall, the proposed research will broaden our knowledge of MT dynamics
and organization and provide insights into management or treatment of MT dysfunction associated diseases.
The mentored phase will be conducted at UC San Diego under the guidance of Professors Yishi Jin and
Andrew Chisholm, renowned experts in genetics and neurobiology. UCSD and neuroscience faculties provide
an excellent environment for the proposed research. I will receive hands-on training in in vitro phase separation
and in vitro MT analysis from Prof. Lizhen Chen and Prof. Arshad Desai, respectively. Mentorship from additional
experts, including Professors Nicholas Spitzer and Sreekanth Chalasani, will help me transition to an
independent research career. Altogether, this research will deepen our understanding of how cells regulate MT
dynamics at the cortex, advancing knowledge of cellular morphogenesis and membrane functions, which are
critical for understanding and treating diseases such as Alzheimer’s, microcephaly, and ALS.

Public health relevance
Project Narrative Microtubule (MT) dysfunction is linked to various developmental and neurological disorders, as well as cancer and aging. Despite significant advances in understanding MT structure and function, their regulation at cellular membranes remains poorly understood. This project aims to elucidate the mechanisms regulating MT dynamics at biological membranes and to identify novel regulatory factors involved in this process.